EEG: Analytical Approaches and Applications

Abstract Sapien Labs is proposing a virtual symposium “EEG: Analytical Approaches and Applications” to take place on July 26/27 2021. The symposium will be cross-disciplinary and will have the goal of enabling perspectives and dialogue to advance the field of electroencephalography (EEG). Through a speaker series, panel discussion, and set of Rapid Talks, the conference will encourage the exploration of new tools and analytical approaches designed to yield better outcomes in neurological and psychiatric health, and to foster increased standards of reproducibility. As EEG is a relatively small field, there are few forums dedicated to the sharing and dissemination of EEG tools and approaches. Thus, we aim to bring together researchers working on various analytical approaches to EEG, as well as signal processing at different levels of resolution and their application to different conditions such as pain, sleep, seizure. neurodegenerative diseases and mental and cognitive health. The focus will be on sharing of new tools and algorithms and bringing together the latest advances in their application. Sessions topics will include A. EEG Tools and Resources, B. New Analytical Methods in EEG, C. Advances in EEG Software, and D. Applications in EEG Cognition. The Conference Organizing Committee will ensure the representtion of women and nationally under-represented minorities through the careful and inclusive selection of speakers, and will enable free participation of large numbers of students and post-docs.

Public health relevance
NARRATIVE Analysis of EEG signals is important for delivering accurate and meaningful insights into brain health, yet research on EEG is largely centered on clinical applications and outcomes. We propose a virtual symposium focused specifically on EEG techniques and analytics in order to expose researchers to diverse perspectives and the sharing of approaches across disciplines. The scientific community is expected to benefit from the dissemination of techniques which will ultimately be applied to improve the detection, diagnosis and treatment of conditions in neurologic and mental health.